Structure and function of Borna disease virus polymerase

Project Summary/Abstract
Non-segmented negative strand (NNS) RNA viruses are highly diversified eukaryotic viruses including
significant human pathogens (e.g., rabies, Nipah, Ebola). Most NNS RNA viruses replicate in the cytoplasm of
host cells, whereas Borna disease virus 1 (BoDV-1), a unique NNS RNA virus, replicates in the nucleus. BoDV-
1 is a causative agent of fatal neurological diseases in animals and humans, although in rare cases. Interestingly,
endogenous bornavirus-like elements were discovered as fossils of ancient bornaviruses in genomes of various
vertebrates including humans, indicating that there have been interactions between bornaviruses and vertebrate
hosts during evolution. Thus, elucidation of unique strategies of bornaviruses to replicate in host cells is important
not only to understand the basic biology of bornaviruses but also to develop therapeutic targets against
bornaviruses with zoonotic potential. The goal of this project is to elucidate the enzymatic roles of the RNA-
dependent RNA polymerase (RdRp) complex composed of the BoDV-1 L and P proteins in transcription and
replication. We hypothesize that (1) the BoDV-1 L protein has enzymatic activities to carry out genome
transcription and replication and (2) the multimeric P protein plays structural roles in maintaining a
transcriptionally active state of the L protein. These hypotheses will be tested by the specific aims to elucidate
the roles of (1) the BoDV-1 L protein in RNA synthesis and processing and (2) the P protein in the formation of
a transcriptionally active RdRp complex. In Aim 1, we will dissect the mechanisms underlying the formation of
the unique termini of the genome and the 5′-terminal cap core structure on mRNAs with the BoDV-1 L-P complex.
In Aim 2, we will solve a 3D structure of the BoDV-1 L-P complex and investigate the mechanism of the activation
of the L protein with the multimeric P protein in RNA synthesis. Collectively, this study will advance our
understanding of how the L protein of BoDV-1 carries out RNA synthesis and processing together with its co-
factor P protein. Furthermore, this study will reveal structural similarities and differences between RdRp
complexes of nuclear- and cytoplasmic- replicating NNS RNA viruses.

Public health relevance
Project Narrative Borna disease virus 1 (BoDV-1), a nuclear-replicating non-segmented negative strand RNA virus, is a causative agent of fatal neurological diseases in animals and humans. Currently, the molecular mechanisms of transcription and replication of BoDV-1 remain largely unknown. The goal of this project is to elucidate the enzymatic and structural roles of the BoDV-1 RNA-dependent RNA polymerase subunits in RNA synthesis and processing.